Center for Personal Dynamic Regulomes

Project Summary
Tens of thousands of human genomes have been sequenced, but the central challenge
is their interpretation. A comprehensive set of regulatory events across a genome—the
regulome—is needed to make full use of genomic information, but is currently out of
reach for most clinical applications and biological systems. The proposed Center will
develop technologies that greatly increase the sensitivity, speed, and
comprehensiveness of understanding genome regulation. We will develop new
technologies to interrogate the transactions between the genome and regulatory factors,
such as proteins and noncoding RNAs from single cells, and integrate variations in DNA
sequences and chromatin states over time and across individuals. Novel molecular
engineering and biosensor strategies are deployed to encapsulate the desired complex
DNA transformations into the probe system, such that the probe system can be directly
used on very small human clinical samples and capture genome-wide information in one
or two steps. These technologies will be applied to clinical samples with genomic
aberrations to exercise their robustness, and reveal for the first time epigenomic
dynamics of human diseases during progression and treatment. These technologies will
be broadly applicable to many biomedical investigations, and the Center will disseminate
the technologies via training and diverse means.

Public health relevance
Project Narrative How genes are turned on and off govern the outcome and treatments of many human diseases. By making it possible to track all the genetic switches rapidly and comprehensively from small human biopsies, the Center aims to greatly improve the precision and effectiveness of disease diagnosis and treatment, such as for cancer, autoimmunity, and neurodegenerative diseases.